ANCILLARY STUDY OF BMD IN PATIENTS ON INHALED CORTICOSTEROIDS/COPD

The purpose of this study is to determine whether the use of inhaled triamcinolone has an effect on the thickness or strength of your bones (bone mineral density).